Unraveling mechanisms of tumor suppression in lung cancer

PROJECT SUMMARY
Genome sequencing has catalogued the somatic alterations in human cancers and identified many
putative tumor suppressor genes. However, human cancers generally evolve through the sequential
acquisition of multiple genomic alterations and simply identifying recurrent genomic alterations does not
necessarily reveal their functional importance to cancer growth. Genetically engineered mouse models
uniquely enable the introduction of defined genetic alterations into normal adult cells, which results in the
initiation and growth of tumors entirely within their natural in vivo setting. However, the breadth of their utility is
limited by the fact that they are neither readily scalable nor sufficiently quantitative. To increase the scope and
precision of in vivo cancer modeling, we previously integrated conventional genetically engineered mouse
models, CRISPR/Cas9-based somatic genome engineering, and quantitative genomics with mathematical
approaches. Tumor barcoding coupled with CRISPR/Cas9-mediated gene inactivation and high-throughput
barcode sequencing (Tuba-seq) enables the parallel investigation of multiple tumor genotypes in individual
mice and allows the large-scale analysis of pairwise tumor suppressor alterations. In Aim 1, we will employ our
multiplexed and quantitative Tuba-seq approach to quantify the impact of inactivating many uncharacterized
putative tumor suppressor genes on tumor growth in vivo and across time. This analysis will broaden our
understanding of the driving forces of tumorigenesis and uncover the potential clinical meaning of these
genomic alterations. In Aim 2, we will uncover epistatic genetic interactions between tumor suppressor genes
by generating de novo tumors with pairwise combination of tumor suppressor alterations. We will generate the
first broad-scale functional understanding of the combinatorial effects of genomic alterations within an
autochthonous cancer model. We will uncover the epistatic interactions of these genes and pathways,
illuminating novel aspects of tumorigenesis, and potentially highlighting therapeutic vulnerabilities. In Aim 3, we
will uncover the molecular programs in cancer cells of different genotypes. To gain insight into how the
molecular outputs of single genomic alterations relate to the effects of pairwise alteration, we will also
characterize tumors with combined inactivation of cooperative tumor suppressors. This will provide a molecular
framework to understand the effects of novel tumor suppressors and uncover the molecular logic that drives
the pattern of genomic alterations in human cancer. Our preliminary data, novel genetic systems, and strong
collaborative team make us uniquely positioned to conduct these studies. The results of this proposal will be
significant because these innovative, multidisciplinary, and highly quantitative approaches will accelerate our
understanding of the determinants of cancer growth and will begin the systematic deconvolution of gene
function during lung cancer growth in vivo.

Public health relevance
NARRATIVE Genome sequencing has catalogued the somatic alterations in human lung cancers and identified many putative tumor suppressor genes. To uncover the impact of novel tumor suppressors and combinatorial genomic alterations on tumor growth, we will use highly quantitative autochthonous mouse model systems. By uncovering the global gene expression and chromatin accessibility states induced by defined alterations, we will also provide insights into the molecular determinants of cancer growth in vivo.